Thermostable RG1-VLPs, a candidate broadly protective HPV vaccine for the prevention of cervical cancer

Project Summary/Abstract: HPV is a necessary cause of 10% of all cancers of women globally, including
99% of cervical cancers. Rates of cervical cancer vary markedly by geographic region and level of economic
development, with >85% occurring in developing countries. Successful prophylactic vaccination against hrHPV
types can prevent dysplasia and thus cervical cancer. Global estimates of HPV vaccination delivery and cervical
screening by region and income level show virtually no significant delivery to many poorer populations of women
worldwide. There are 13 hrHPV types plus a group of 11 possibly carcinogenic types. Licensed HPV vaccines
all target HPV16 and HPV18, and one also targets the next five most common types in cervical cancer. Since
they do not target all cancer-­associated HPV types, screening must be maintained even in vaccinated women,
adding to medical costs. In addition, the stringent cold-­chain requirements of HPV vaccines provide a serious
impediment to their delivery in developing countries. Our overall goal is to develop an affordable HPV vaccine
that both extends the breadth of protection to all cancer-­associated HPV types, and is stable at ambient
temperature. Here we address this goal with two innovations: 1) displaying an L2-­based protective epitope (RG1)
that is conserved for HPVs in a unique position on the surface of HPV16 L1 VLPs, producing a single antigen,
broadly protective HPV vaccine technology, RG1-­VLP, and 2) the RG1-­VLP vaccine is formulated on alum and
embedded in glassy organic matrices formed by adjusting lyophilization and formulation parameters in order to
control ice crystal nucleation rates, glass transition temperatures, and other material properties and thereby
protect against degradation during processing, shipping and storage.
HYPOTHESIS 1: Cold chain storage properties are a significant barrier to the distribution of current HPV vaccines,
and the development of a powdered RG1-­VLP vaccine including adjuvant that is thermostable will address this
need. Specific Aim 1: Develop a GLP freeze-­dry protocol for a powder formulation of RG1-­VLPs in alum and
study its in vitro temperature stability, and in murine models its immunogenicity and protective efficacy in
comparison to Gardasil9.
HYPOTHESIS 2: RG1-­VLP vaccination is safe and well tolerated. Specific Aim 2: To perform a Dose Escalation
Phase I Trial of the Safety and Immunogenicity of thermostable RG1-­VLP in 36 healthy female volunteers with
the inclusion of a control Gardasil9 arm in the study.
HYPOTHESIS 3: RG1-­VLP vaccination of healthy women induces broadly protective serum antibody. Specific
Aim 3: To analyze the levels of protective antibodies in the serum of patients from the phase I study induced by
RG1-­VLP vaccination or Gardasil9. We will utilize the passive transfer assay to measure protective responses,
as well as L2 and L1 VLP ELISA and in vitro neutralization assays to quantify antigen-­specific neutralizing
antibody titers in serum.

Public health relevance
Project Narrative Oncogenic human papillomavirus (HPV) infection is a necessary cause of 10% of all cancers of women globally, including 99% of cervical cancers. To help overcome disparities in primary prevention of cervical cancer, here we seek to develop an affordable HPV vaccine that both extends the breadth of protection to cover all cancer- associated HPV types and is stable at ambient temperature.